Vibrotactile stimulation of the larynx for refractory chronic cough

PROJECT SUMMARY/ABSTRACT
Chronic cough affects millions of people in the US and around the world, and has a significant negative impact
on quality of life, especially when it is refractory to treatment. Existing treatments for chronic cough can help,
but up to 50% of patients have persistent cough symptoms despite receiving standard treatments. Identifying
effective treatments for refractory chronic cough aligns with the mission of the NHLBI to advance the treatment
of lung and related diseases, enhancing “the health of all individuals so that they can live longer and more
fulfilling lives.” A promising approach to treating refractory chronic cough is laryngeal vibrotactile stimulation,
which changes sensory input to the larynx with the goal to break the vicious cycle of cough causing laryngeal
irritation and increased sensitivity, which in turn causes more cough. Chronic cough is associated with
abnormalities in laryngeal sensorimotor cortex activity in areas that can be modulated by the use of laryngeal
vibrotactile stimulation. In preliminary findings, the use of laryngeal vibrotactile stimulation was associated with
an improvement in cough-related quality of life and cough counts, and participants expressed interest in
increased laryngeal vibrotactile stimulation dosing. In Aim 1 of this proposal, dose refinement for vibrotactile
stimulation will be performed, using a series of escalating dose conditions. The most favorable dosing will be
identified, taking into account acceptability and tolerability for participants as well as changes in cough-related
quality of life and objective cough counts. In Aim 2, a pilot randomized controlled trial will be conducted to
measure the effect of 4 weeks of laryngeal vibrotactile stimulation use on key cough outcomes. Data on
acceptance of randomization and retention will be collected. Changes in cough-related quality of life, cough
severity, and objective cough counts will be measured. These aims will be conducted by a multidisciplinary
research team with expertise in pulmonology, laryngeal physiology and function, clinical trials, biostatistics, and
medical devices, in partnership with an extensive and engaged network of referring providers. Completion of
these aims will provide necessary and sufficient information about the feasibility and acceptability of a
subsequent randomized clinical trial to definitively test the effect of laryngeal vibrotactile stimulation on
refractory chronic cough. In addition, the proposed project will provide a preliminary estimate of the effect of
laryngeal vibrotactile stimulation on cough-related quality of life as well as an estimate of the resources needed
to conduct a subsequent definitive clinical trial. This study has the potential to lead to a non-invasive, portable,
repeatable treatment free of systemic side effects for the millions of people who suffer from refractory chronic
cough.

Public health relevance
PUBLIC HEALTH RELEVANCE Chronic cough that does not respond to standard cough treatments (known as refractory chronic cough) is highly disruptive and significantly reduces well-being. The proposed studies will lay the groundwork for a larger clinical trial of the use of vibrotactile stimulation to the larynx to reduce refractory chronic cough via dose refinement (Aim 1) and conduct of a pilot randomized clinical trial (Aim 2). This potential treatment is noninvasive, repeatable, independently usable, and portable, making it a promising option for improving the quality of life of people who suffer from refractory chronic cough.